Structural Dynamics of GPCR Oligomerization: Impact on Localization and Signaling

ABSTRACT
G protein-coupled receptors (GPCRs) are crucial in cellular signaling, transducing extracellular
stimuli into intracellular responses. Predominantly located on the plasma membrane, GPCRs are
vital in numerous physiological processes, making them key pharmacological targets. Emerging
evidence also indicates roles for some GPCRs in various intracellular compartments, signaling in
cooperation with soluble molecules or other cellular pathways. Significant advancements in
structural biology have enabled the determination of over 350 GPCR structures in complexes with
signaling partners, predominantly with G proteins (~96%), but also with β-arrestins (3%) and
GPCR kinases (<1%). Nonetheless, our comprehension of their interactions with other regulatory
proteins, such as chaperone proteins and membrane-associated proteins, and how these
interactions influence GPCR localization and signaling diversity, remains poorly understood. This
grant proposal aims to elucidate the structural and mechanistic basis of GPCR localization
regulation and signaling diversity, focusing on two primary objectives. 1) Structural
characterization of non-Class B GPCRs localization regulated by RAMPs. We propose a detailed
structural analysis of a few non-Class B GPCRs in complex with Receptor Activity-Modifying
Proteins (RAMPs), concentrating on their roles in GPCR cell surface localization, ligand
recognition, and functional specificity. 2) Unraveling GPCR interactions with PDZ proteins and
membrane-associated regulators in cell surface retention and signaling. Our objective is to dissect
the structural and mechanistic aspects of GPCR interactions with PDZ domain-containing proteins
and other membrane-associated regulators. These interactions are crucial in regulating GPCR
cell surface retention, turnover dynamics, signal diversity, and spatial dynamics. We will intensify
our efforts in optimizing and applying state-of-the-art technologies in structural characterizations
(Cryo-EM, X-ray crystallography, MD simulations), as well as integrate mutagenesis studies,
advanced fluorescence imaging techniques, and cell biology-based signaling measurements to
provide a comprehensive understanding of these regulatory mechanisms. Our research seeks to
develop a thorough understanding of GPCR-regulator complexes, examining their spatial and
functional dynamics. We aim to uncover novel insights into the molecular mechanisms regulating
GPCR localization and signaling diversity, applicable to various GPCR families. This will not only
enhance our multifaceted understanding of GPCR biology, but may also pave the way for novel
approaches in therapeutics targeting the impaired trafficking and functioning of GPCRs.

Public health relevance
NARRATIVE This project seeks to unravel the complex structural relationships governing G protein-coupled receptors (GPCRs), focusing on their interactions with chaperone and membrane-associated proteins, which were less structurally characterized yet. Employing cutting-edge techniques like Cryo-EM, crystallography, and molecular dynamics simulations, validated with extensive cell- based imaging and signaling assessment methods, the research aims to reveal the molecular determinants that govern these critical interactions and their implications in regulatory mechanisms of GPCR localization and signaling diversity. These insights promise to significantly advance our understanding of GPCR systemic regulation and pave the way for novel therapeutic interventions.